Structural Parameters Involved in Metal Recognition

[unreadable] DESCRIPTION (provided by applicant): The mechanisms by which organisms control transition metal ions and the roles of these metals in cellular regulation have emerged as key areas of investigation in metallobiochemistry. Specific metal binding and responses are required by biological systems in order to avoid cross talk between metals in the expression of proteins, in the uptake of specific metals, and for the incorporation of the correct metal into enzyme active sites. The details of how the metalloproteins recognize, bind and respond to the presence of the requisite metal ion is not well established. This is particularly true for transition metal ions, many of which have similar charges and ionic radii. Thus, it seems likely that coordination geometry and ligand preferences (at least among the ligands provided by amino acids) play important roles in distinguishing transition metals. This proposal seeks to use biophysical methods aimed at delineating structural parameters that are involved in determining metal specificity. The overall objective of this research project is to understand the structural parameters that underlie metal specific binding, and the related protein structural responses to specific metal binding, in metalloproteins involved in metal trafficking. Toward this goal, we plan to examine the structural parameters involved in a metalloregulator (NikR), a metallotransporter (NikABCDE) and a metallochaperone (HypB)--proteins all involved in nickel trafficking in E. coli. The viability of bacteria, including human pathogens, is linked to the acquisition of required metals, and several human diseases have been shown to result from a breakdown in metal trafficking (e.g., Wilson's and Menkes' diseases for copper, genetic hemochromatosis and other hereditary iron overload disorders for iron). A detailed understanding of metal trafficking is thus important to understanding metal metabolism and its effect on human health, and requires an understanding of mechanisms by which metalloregulators, metal transporters and chaperones specific to each required metal operate. In addition, a detailed understanding of the structural parameters involved in metal-trafficking may lead to the design of new antibiotics that interfere with bacterial metal metabolism, which is frequently essential for pathogenesis, and the development of plants that are resistant to metals and useful in bioremediation. [unreadable] [unreadable]